Mechanisms by which Bok binds to IP3Rs and regulates mitochondrial dynamics

PROJECT SUMMARY The Bcl-2 protein family is a group of proteins that plays an important role in intrinsic apoptosis and includes the protein Bok. While many members of the Bcl-2 protein family have been thoroughly studied, Bok is a very poorly understood protein, with pro-, anti-, and non-apoptotic properties reported. Our lab has shown previously that Bok is constitutively bound to inositol 1,4,5-trisphosphate receptors (IP3Rs), which are tetrameric calcium channels found in the endoplasmic reticulum (ER) membrane of mammalian cells. While other Bcl-2 protein family members have been reported to interact with IP3Rs, the Bok-IP3R interaction is much more efficient, with essentially all Bok bound to IP3Rs. We have shown that Bok interacts with IP3Rs in all tissues, including cerebral cortex and hippocampus. Additionally, we have discovered that Bok protects IP3Rs from proteolytic cleavage, and in the absence of IP3Rs, Bok is ubiquitinated and rapidly degraded by the proteasome. Recent data has shown that Bok promotes mitochondrial fusion, and Bok knock-out mouse embryonic fibroblast cells have more fragmented mitochondria compared to control cells. Since Bok is expressed highly in hippocampal neurons, and mitochondrial dysfunction can often lead to neurodegenerative disease, it is possible that Bok plays a role in the development of neurodegenerative disease. Therefore, the current aims of this study are 1) to determine how ER-bound Bok promotes mitochondrial fusion activity and 2) to define the exact nature of the Bok-IP3R binding interface. Results from these aims will fill our current gaps in knowledge regarding Bok’s role in the cell and the Bok-IP3R interaction, and can contribute to our overall knowledge of the various functions of the Bcl-2 protein family.

Public health relevance
PROJECT NARRATIVE Mitochondrial dysfunction can cause an array of diseases, ranging from congenital metabolic disorders to age- related neurodegenerative disease. Bok is a member of the Bcl-2 protein family that we recently discovered promotes mitochondrial fusion despite its localization to the endoplasmic reticulum and constitutive association with inositol 1,4,5-trisphosphate receptors (IP3Rs). The proposed research aims are to better understand how Bok promotes mitochondrial fusion and further characterize the Bok-IP3R interaction.